International Seizure and SUDEP Research Repository (InSSURR)

Project Summary
Sudden Unexpected Death in Epilepsy (SUDEP) is the commonest category of direct epilepsy related mortality
worldwide. It is designated by NIH-NINDS as an Epilepsy Research Priority Benchmark (Area IV). Generalized
convulsive seizures in patients with early onset, longstanding epilepsy, and who live alone, pose major risk.
There are no specific SUDEP interventions other than general strategies to reduce seizure frequency. Research
into biomarker identification and specific prevention approaches has been hindered by the lack of largescale,
prospectively acquired, long term (multi-day or longer), multimodality datasets that allow comprehensive study
of seizures for clues to mechanisms of death. Understanding mechanisms will allow development of specific
preventive methods. Identifying biomarkers will identify those at maximum risk, who stand to gain the most from
knowledge of preventive strategies. The goal of this data resource project, the International Seizure and SUDEP
Research Repository (InSSURR), is to overcome the barriers posed by the lack of high-quality datasets for
research. InSSURR will be the single largest resource of its kind, expanded from three foundational US and
European resources, a) the previously NINDS funded Center for SUDEP Research (CSR) study; b) the French
Health Ministry funded European Réseau national d’Etude des facteurs prédictifs et de la Prévention
des Morts Soudaines inattendues dans les Epilepsies partielles pharmacorésistantes (REP02MSE) study; and
c) the University of Texas at Houston SUDEP research database. InSSURR will ingest seizure and SUDEP data
from ongoing and future studies to create the largest publicly available epilepsy mortality research data resource.
We will serve the epilepsy research community by creating Epi-Arch, an integrated, expandable, metadata-
mapped, data resource of >4200 persons with epilepsy (many with SUDEP) with electroencephalography, EKG,
breathing, sleep and MRI data. We will develop and operationalize Epi-Port, a web-based portal for ingestion
and curation of new data, and access to search and visualize the data resource using a cloud-based platform in
a secure, robust, and scalable manner. We will make Epi-Tools available to the research community - a suite of
data curation, data integration and signal processing tools to facilitate further offline data analysis. We will serve
the SUDEP research community by: a) developing and providing access to web-based technical documentation
for InSSURR, b) providing training resources, c) providing technical support, and d) supporting a user community
site. In summary, by the end of the four-year project period, InSSURR will promote and enable epilepsy, seizure
mortality and sleep research by creating a unique NINDS resource with an expanding database of >5000
research epilepsy datasets, and a vibrant community of end-users. In so doing, InSSURR will create a FAIR
(findable, accessible, interoperable, and reusable) data ecosystem to provide an unprecedented international
research data resource for SUDEP and epilepsy research.

Public health relevance
Project Narrative Sudden Unexpected Death in Epilepsy (SUDEP) is a significant public health problem which is little understood, and for which there are no validated biomarkers or targeted means of prevention. There has previously been a dearth of data with which to study how and why death occurs in order to prevent SUDEP. This data deficiency is addressed by the International Seizure and SUDEP Research Repository (InSSURR), the largest such data resource in the world.